Selective Catalytic Strategies for Carbohydrate Synthesis

Project Summary
Rare and unnatural carbohydrates play an essential role in the potency and selectivity of hundreds of bioactive
natural products and pharmaceutical compounds. These scaffolds often feature unusual relative/absolute
stereochemistry, pyranose/furanose ring branching, heteroatom substitutions, and varying degrees of
deoxygenation. Despite the biological significance of rare and unnatural sugars, synthetic challenges limit access
to these important molecules. Due to their functional group density and stereochemical complexity, the synthesis
of rare and unnatural sugars requires multistep chemical synthesis, and commonly relies on protecting group
manipulations to achieve selective reaction outcomes. New, selective methods are needed for the expedient
synthesis of pyranose and furanose sugars. This proposal describes the development of selective radical
reactions to transform unprotected and minimally-protected carbohydrates into diversely functionalized
monosaccharides and glycans. We specifically target epimerization reactions, C-C bond forming reactions, and
radical rearrangements to achieve broad synthetic access to sugar isomers, branched-chain sugars, and
deoxygenated sugars, respectively. Using state-of-the-art synthetic, mechanistic and theoretical tools, our
approach involves the identification of new catalytic strategies to control bond breaking, bond forming, and
radical reorganization steps within the context of complex glycan molecular frameworks. The successful
development of this proposed research is anticipated to transform carbohydrate synthesis, dramatically reducing
the time and resources necessary to access these complex pharmacophores. Fundamental mechanistic findings
revealed en route to this goal are further anticipated to contribute significantly to our understanding of
carbohydrate reactivity patterns and to lay the groundwork for catalytic approaches to selective radical
functionalization reactions, more broadly.

Public health relevance
Project Narrative Rare and unnatural carbohydrates play an essential role in the potency and selectivity of over 100 FDA-approved drugs and countless bioactive natural products. However, in spite of their importance to human health, synthetic challenges limit access to these important pharmacophores. The research described in this proposal seeks to develop new catalytic methods for the selective synthesis of diverse carbohydrate structures to enable the study and treatment of human disease.